DEVELOPMENT OF IMAGE ENHANCEMENT RADIOPHARMACEUTICALS FOR THERAPY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This laboratory carries out research on the development of image enhancement agents and radiopharmaceuticals for therapy. The laboratory is in the Division of Radiological Sciences in the Mallinckrodt Institute, Department of Radiology, Washington University Medical School and has eight faculty members, five post doctoral Research Associates, two graduate students and approximately 16 support staff. The laboratory operates two cyclotrons and a linear accelerator for radionuclide production and maintains state-of-the-art equipment for synthesis, separation and quality control of agents for imaging and therapy. Research is carried out in development of both inorganic and organic compounds for positron emission tomographic (PET), single photon emitted tomographic (SPECT) and magnetic resonance (MR) imaging applications. Radiopharmaceuticals are also developed for the investigation of targeted radiotherapy.